Ovarian cancer risk stratification using circulating miRNAs to assess BRCAness

Abstract
Current strategies to prevent ovarian cancer deaths remain limited. Unlike breast and colon cancer, clinical trials
for early detection of ovarian cancer have not been effective at reducing ovarian cancer deaths. In contrast, risk-
reducing salpingo-oophorectomy for women with germline mutations in BRCA1/2 reduces the risk of ovarian
cancer death by more than 95%. However, since current guidelines limit genetic testing to individuals with a
personal or close family history of breast or ovarian cancer, only 10% of the estimated 1 million Americans with
BRCA1/2 mutations are aware of their mutation status. We have shown that BRCA1/2 mutation carriers have a
distinct serum microRNA (miRNA) profile which can be used to rapidly identify likely mutation carriers. In this
proposal, we will use previously collected sample and datasets to discover the generalizability of this miRNA
profile to other potentially high-risk groups. We will examine the serum miRNA profiles of both BRCA1/2 mutation
carriers as well as carriers of mutations in other DNA repair genes and women with no discernible germline
mutation but a strong family history of breast or ovarian cancer. Samples will be classified in terms of BRCAness,
i.e., how closely they resemble BRCA1/2 mutation carriers versus healthy controls with average cancer risk. We
will determine whether the BRCA1/2 miRNA profile is restricted to alterations in these specific genes or reflects
a more general deficiency in DNA repair which could increase the risk of ovarian cancer. Independently, we will
test whether the BRCAness miRNA profile is sufficient as an ovarian cancer risk triage tool, even in the absence
of known genetic information. Using a case-control format, we will compare baseline miRNA profiles among a
study population of average risk women who were enrolled in an ovarian cancer screening trial. We will calculate
whether cases were more likely to have a BRCAness miRNA profile at study entry compared to controls. The
final result of these studies will be to test whether serum miRNAs can serve as a biomarker to identify more
women at risk for ovarian cancer who could benefit from risk-reduction strategies. This group can then be
prioritized for future biologic studies and clinical trials.

Public health relevance
Project Narrative Ovarian cancer risk stratification using circulating miRNAs to assess “BRCAness” Risk-reducing surgery is the most effective means to prevent ovarian cancer. Currently, there is no blood test to screen for high-risk individuals who would benefit from this approach. In this proposal, we test the feasibility of a microRNA-based blood test to identify women among the general population with an increased likelihood of developing ovarian cancer.